CALCIUM SUPPLEMENTATION IN PEDIATRIC SICKLE CELL DISEASE

The purpose of this study is to determine whether calcium supplementation improves the bone mineral density of children with SS type sickle cell disease (SCD-SS). Previous studies have shown poor bone mineralization in this group of patients. This 12 month prospective randomized placebo-controlled trial will test whether calcium supplementation will result in significantly improved annual increments in bone mineralization in children with SCD-SS. 56 children, ages 5 to 15 years of age, with SCD-SS and no other conditions known to affect growth or nutritional status, will be enrolled. Enrollment is expected to begin within the next 6 months. Visits will take place at baseline, and at months 6 and 12. Assessments include bone density by dual energy x-ray absoprtiometry, peripheral quantitative computerized tomography and ultrasound. In addition, growth, body composition, puberty status, and dietary intake will be assessed.